The Genomic Function of Estrogen Receptor Beta in Endometriosis

As endometriosis is an estrogen-dependent inflammatory disease, estrogen/estrogen receptor (ER) signaling
has an essential role in the pathogenesis of endometriosis. We revealed that cytoplasmic ERβ interacts with the
apoptosis machinery and inflammasome complex in endometriotic tissues to prevent apoptosis and stimulate
cell proliferation activity, respectively. However, the function of nuclear ERβ in the pathogenesis of endometriosis
has not yet been elucidated. To fill this gap in the scientific knowledge, we have determined the endometriotic
tissue-specific ERβ-regulated transcriptome and ERβ-cistrome by using a novel endometrium-specific ERβ
overexpression mouse model. Our new omics data provided three unique aspects of nuclear ERβ function that
drive endometriosis progression. 1) The increases in anti-apoptosis signaling in the endometrium is one of the
critical drivers that promote the progression of endometriosis. Our omics data revealed that the ERβ/Nuclear
Factor of Activated T-cell 5 (NFAT5) complex directly downregulates the expression of N-Myc and STAT
Interactor (NMI), which stimulates interferon (IFN)α-induced cell death signaling. In Aim 1, we will investigate
the role of NMI in IFNα-induced cell death signaling in the normal endometrium and then identify whether the
ERβ/NFAT5 complex downregulates the expression of NMI in endometriotic lesions to enhance endometriosis.
Since epidermal growth factor receptor (EGFR) signaling is elevated in endometriotic tissue and involved in anti-
apoptosis, we will also investigate the role of EGFR in the ERβ/NFAT5-mediated suppression of NMI expression
in endometriotic tissues. 2) The epithelial-mesenchymal transition (EMT) is a critical step for endometriosis. Our
omics data showed that the ERβ/Early Growth Response Protein 1 (EGR1) axis directly increased the expression
of Fibrillin1 (FBN1), which is an activator of EMT, in ectopic lesions. In Aim 2, we will define the role of FBN1 in
endometriosis-associated EMT in ectopic lesions and then determine whether the ERβ/EGR1 axis upregulates
FBN1 gene expression in ectopic lesions to stimulate EMT in ectopic lesions. Since EGFR signaling also plays
an essential role in EMT, the role of EGFR in ERβ/EGR1 axis-mediated EMT will be investigated. 3) To establish
endometriosis, angiogenesis is activated in ectopic lesions. However, the molecular mechanism of estrogen-
induced angiogenesis in ectopic lesions has not been elucidated. Our data revealed that ERβ elevated the
expression of connective tissue growth factor (CTGF), which is the activator of hypoxia inducible factor 1a
(HIF1A)-mediated angiogenesis, in ectopic lesions. In Aim 3, we will define the role of CTGF in endometriosis-
associated angiogenesis and then determine whether the ERβ/HIF1A axis upregulates CTGF gene expression
in ectopic lesions to stimulate angiogenesis. Since EGFR signaling also plays an essential role in angiogenesis,
the role of EGFR in ERβ/HIF1A axis-mediated angiogenesis will be investigated. Collectively, these three ERβ
gene networks will conceptionally advance our understanding of the molecular etiology of endometriosis and
should provide new molecular therapeutic targets for alternative endometriosis therapies.

Public health relevance
Endometriosis is a clinically significant but poorly understood condition that affects the productivity and well- being of millions of women in their reproductive years. Our proposed research project will define a new Estrogen Receptor β-mediated gene network to understand the molecular mechanism of the inception and progression of endometriosis. This new conceptual advancement should provide new druggable targets to inhibit the survival and progression of endometriosis and reduce the side effects of current endometriosis treatments.